Administrative Core

A robust administrative component is essential for effective management of all cores comprising the West Virginia Clinical and Translational Science Institute (WVCTSI). An established culture of collaboration, productivity, fiscal accountability, and responsiveness to changing needs has been a cornerstone of the WVCTSI since its inception. Our productivity record over the past 4 years that includes 1,325 publications and 951 external funding applications resulting in $159.3 MM in external funding linked to WVCTSI support is evidence of the excellent management provided by the WVCTSI Administrative Core. WVCTSI faculty and staff have and will continue to work seamlessly, resulting in outstanding cross-core collaboration and coordination. We now propose a WVCTSI organizational structure that leverages this veteran team, and brings two new partners, the West Virginia Department of Health and Human Services (the state health department) and Berkeley Medical Center/WVU Eastern Campus. During the next funding cycle, the Administrative Core will achieve the following specific aims: (1) Provide transformational statewide leadership to grow and nurture West Virginia’s clinical and translational research agenda through implementation of effective operational and governance structures that facilitate attainment of all proposed WVCTSI Specific Aims and projects, (2) Create policies and procedures to drive performance, transparency, constructive communication and collaboration among multiple stakeholders (i.e., investigators, healthcare providers, community members), and (3) Provide sound fiscal and resource management, ensuring appropriate resourcing of cores, flexibility to meet changing needs and environments, and sustainability of services. A comprehensive governance plan is presented to ensure transparent decision-making with increased partner institution representation on the WVCTSI Steering Committee while core and staff directors will comprise a new Operations Committee. There are clearly described policies and procedures for resource distribution that provide mechanisms for increasing funding of successful initiatives and decreasing support to initiatives that fail to deliver on agreed upon objectives. With the proposed infrastructure, clinical and translational researchers will have available the requisite support, from inception to project completion, to conduct impactful research relevant to West Virginia’s population, The Administrative Core will leverage leadership strength and experience, enabling research infrastructure to grow, productivity to further increase, and substantial progress to be made on improving the health of West Virginians.